Restoration of Optic Nerve Function Driven by In Vivo Multimodal Electrical Stimulation

Project Summary
To date, no therapy exists to restore vision to the over 64 million people worldwide who are legally blind from diseases
that damage the optic nerve. Although current approaches for regenerating the optic nerve have successfully directed long
distance axon regeneration, these strategies are still limited by the fact that 1) efficacy has generally been demonstrated
when therapies were initiated before axon injury, which has limited clinical application; 2) they may carry a risk of
neoplastic conversion and thus may not be readily deployed prophylactically; and 3) incidences of off target axon
regeneration have been reported, indicating a need not just for signals that promote but also ones that direct axon growth to
intended targets. Our multi-disciplinary collaboration between electrical engineers, neuroscientists, electrophysiologists,
and neurosurgeons has enabled the collection of compelling preliminary data demonstrating that exogenously applied
electric fields (EFs) control the direction of retinal ganglion cell (RGC) axon growth, in-vitro. In vivo, stimulation with
asymmetric waveforms was found to be effective at directing full-length optic nerve regeneration, without evidence of
aberrant targeting, and restoring partial visual function (local field potential recordings in the superior colliculus and pattern
electroretinogram) after crush injury. Interestingly, stimulation with symmetric waveforms was more effective at promoting
RGC survival than asymmetric waveforms. The discovery that different waveforms (asymmetric versus symmetric) may
activate distinct signaling pathways that control different cellular behaviors provides a unique opportunity to assess for
synergistic effects from combined stimulation. Here, we propose to compare the efficacy of combined symmetric and
asymmetric EF stimulation on restoring visual function over either treatment alone. Additionally, although EF stimulation
with asymmetric waveforms was successful at restoring partial visual function, local field potential amplitudes within the
superior colliculus were lower and latencies longer than in normal controls. Whether this dysfunction stems from ineffective
RGC synaptic transmission (spatial summation) or absence of myelin (temporal summation) or both is unknown. Here, we
propose to employ immunohistochemical, transsynaptic viral labeling techniques, and electrophysiology experiments to
interrogate the source of this signaling deficiency. If successful, experiments proposed here have the potential to advance
EF application into a strategy that, when applied synergistically with other approaches for RGC axon regeneration, can help
regenerate the optic nerve and restore visual function of patients blinded by optic neuropathies.

Public health relevance
To date, no therapy exists to restore vision in the more than 64 million people worldwide who are legally blind as a result of diseases that damage the optic nerve, a nerve comprised of retinal ganglion cell (RGC) axons that relay visual information from the eye to the brain. The proposed research builds upon promising results by our group showing that electric fields direct regeneration of RGC axons in vitro and in vivo, even when applied after degeneration has started to set in. This project will lay the groundwork for the future development of a breakthrough electric field-based therapy to regenerate the optic nerve using novel waveforms and systems.